Novel causal inference methods to inform clinical decision on when to discontinue symptomatic treatment for patients with dementia

PROJECT SUMMARY/ABSTRACT
Appropriate use of acetylcholinesterase (AChEIs) and memantine can meaningfully improve the health
outcomes and quality of life among people with Alzheimer’s disease-related dementia (ADRD). Deprescribing
of these symptomatic medications can help mitigate medication burden and associated adverse events in this
population, particularly given the high level of multimorbidity and pill burden. However, no current US guideline
exists on deprescribing of these medications in ADRD. Existing non-US guideline recommendations are largely
consensus-based and should be strengthened through higher levels of evidence. Two pivotal questions need
to be answered first: 1) what is the long-term effect of symptomatic dementia medications? and 2) when is
suitable to discontinue these medications? Ideally, answers to these questions would come from randomized
controlled trials, but conducting trials evaluating multiple treatment duration or discontinuation strategies
simultaneously with large enough sample sizes in each arm would be cost-prohibitive. Observational data from
dementia medication use in the real-world setting provides a unique opportunity. However, treatment duration
or discontinuation strategies necessarily involve interventions on time-varying treatment decisions. Evaluating
the time-varying medication use on health and patient-centered outcomes must appropriately control for
complex time-varying confounding that renders conventional regression invalid. Novel causal inference
methods, including Robins’ g-formula and a three-step weighting approach (cloning, censoring, weighting) can
appropriately account for such time-varying confounding and generate estimates of absolute risks while
preventing immortal time bias. By emulating the valid analyses of trials, causal analyses of observational data
are also cost-efficient and have greater generalizability. Using data collected in a large survey linked with
electronic health databases, we will characterize the utilization pattern of symptomatic dementia medications
and examine factors that influenced treatment discontinuation (Aim 1). We will then use novel causal inference
methods to estimate the long-term effect of continuous treatment (Aim 2), and to evaluate different treatment
discontinuation strategies (Aim 3) with regard to incidence of clinical and patient-centered outcomes and health
service utilization. We will use data from the Health and Retirement Study (HRS)-Medicare linked dataset. The
nationally representative, longitudinal, NIA-funded HRS survey provides validated measures on cognitive
impairment and dementia. The linkage to Medicare provides extensive information on medication, clinical
characteristics, and health care utilization. The expected outcome of this study is an understanding of the
effects of long-term use of dementia medications and the impact of different treatment discontinuation
strategies on outcomes. The findings of this study will provide a scientific basis for the development of
evidence-based guidelines and the planning of clinical trials in the deprescribing of symptomatic dementia
medications in people with ADRD to improve their care.

Public health relevance
PROJECT NARRATIVE Optimizing dementia treatment through deprescribing can help avoid adverse drug effects and improve outcomes for patients with ADRD, but it is unclear when it is best to discontinue these medications. We will use longitudinal data collected from real-world setting and apply novel causal inference methods to estimate the long-term effect of symptomatic dementia medications and identify the optimal timeframe to discontinue these medications. The findings will inform development of evidence-based guideline recommendations in the deprescribing of dementia medications and improve care in this population.